Engineering of Stretchable Neural Interfaces Using Liquid Metals for Stable Electrical Communication and Adaptive Stiffness Transformation

PROJECT SUMMARY
After decades of using implantable neural probes with implantable multielectrode arrays for medical studies,
the exact failure mechanisms of these implants still remain to be fully understood. However, more and more
studies have shown that minimizing the mismatches between the soft biological tissue and bioelectronic
devices would be a key to achieving long-term, accurate, real-time, and large-scale neural recordings and
stimulations without inflammatory immune responses. To mitigate the mechanical mismatch found in hard
metal or silicon probes, soft neural probes that are both flexible and stretchable have been developed in
recent years. However, bioelectronics on current soft probes has fundamental limits in the stability of their
electrochemical impedance under physiological conditions, resulting in a compromise between electronic
performance and mechanical matching. The long-term goal is to create a next-generation brain-computer
interface (BCI) for advancement in biology, neuroscience, biomedical engineering, and regenerative
medicine. The overall objective of this application is to elucidate the design rules to enable electronic-tissue
interfaces with reliable electrochemical impedance, tunable mechanical stiffness, using an approach that
combines two unique material types – nontoxic liquid metals and biocompatible elastomers. The central
hypothesis is that a combination of low-melting-point nontoxic gallium-based liquid metals and intrinsically
stretchable polymers will synergistically enhance the electrical, and mechanical interfacial properties in the
biological environment and provide unified interfaces for multifunctional integrated systems with embodied
intelligence. The successful completion of this research will result in significant advances in the methodology
of liquid-metal-embedded soft neural probes. The rationale underlying the proposed research is that the
successful development of a truly stretchable and reliable probe-tissue interface offers neuroscientists an
unprecedented platform technology to design specific neural probes to investigate fundamental life science
questions that were unexplorable before, such as “how neuronal circuits are formed during brain
development” where high-density high-resolution stretchable neural probes are needed as a mammalian
brain may grow more than 100% in size and add vast amounts of new tissue and resulting new functions.
The proposed research is innovative, because it departs from both the conventional and existing
neuroscientific instrumentations and introduces a new framework for next-generation neural probe systems
using low-melting-point metals and soft polymers. The proposed research is transformative because it will
enable “invisible” brain-computer interfaces (BCI) to provide fundamental insights into the underlying
physics of brain circuitry formation and functionality. Ultimately, such knowledge paves the way for us to
understand the brain and ourselves better, offers new opportunities for finding the origin of intelligence, and
invites new solutions for the development of innovative therapies to treat brain disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing a new and alternative strategy to create neural interfaces that simultaneously minimize the electrical, mechanical, and biological mismatch between artificial devices with the nervous system and provide a unique opportunity to achieve long-term, accurate, real-time, and large-scale neural recordings and stimulations free of the foreign body response. Once such strategies have been developed, there is the potential for a significant advance in understanding brain development, disorders, and related behaviors as well as precise treatments to clinical disorders. Thus, the proposed research is relevant to the part of NIH’s mission to seek fundamental knowledge of the nature and behavior of living systems and use it for reducing illness and disability.